NH PHL Discipline D Special Project Track 1 - sample collection

Discipline D: Special Projects Track 1: Sample Collection NH PHL will recruit the assistance of two New Hampshire regulatory agencies for their assistance with sample collection. This collaboration will allow the NH PHL to meet the goals of this cooperative agreement. Funds provided under this track must be utilized to: compensate the sampling organization for collecting samples, purchase supplies for the sampling organization to utilize during sample collection, pay for shipping costs, and to pay for samples purchased at the manufacturer or retail location. NH PHL has reached agreements with both the New Hampshire Department of Health and Human Services Bureau of Food Protection (NH BFP) Food Protection Program, as well as the New Hampshire Department of Agriculture, Markets and Food (NH DAMF) Division of Regulatory Services to develop annual sample plans and obtain human and animal food products for testing at NH PHL. Both NH entities have been trained in FDA-approved sample collection and have demonstrated competency in maintaining sample integrity, aseptic sampling, and proper chain of custody. These agreements are outlined briefly in the Letters of Support provided by each of these agencies, and will provide a stronger framework of Food Protection in the State of New Hampshire.

Public health relevance
Project Narrative - Discipline D: Special Projects - Track 1: Sample Collection The New Hampshire Public Health Laboratories (NH PHL) will work with regulatory agencies in New Hampshire to collect food samples for testing. These collaborations will allow for the purchase sample collection supplies, pay for retail samples and reimburse the regulatory agencies. This coordination will allow the NH PHL to assist with inspections and investigations performed by these regulatory agencies, and the removal of adulterated food products from commerce.